Enhanced Echinobase: A Community Genome Resource for the Future

ENHANCED ECHINOBASE: A COMMUNITY GENOMICS RESEARCH RESOURCE FOR THE FUTURE
Overall Summary
Echinobase (Echinobase.org) is a database that houses all of the diverse genomic data types produced by
biologists working with echinoderms. It is accessed through a website that allows scientists to search, view and
download a range of datatypes to empower their own research. Echinoderms are one of only three major
phyla within the deuterostomes, and therefore the species within this clade encompass a large taxonomic
diversity of body plans. Species of echinoderms are powerful model systems for understanding the processes
by which the genome controls development. For example, they have uniquely contributed to understanding
how gene expression is regulated in time and space and how networks of interacting genes, or Gene
Regulatory Networks (GRNs) control development. The proposal here will migrate current Echinobase data to
a customized clone of Xenbase with underlying Chado schema. As a consequence, Echinobase will inheriting
enhanced database functionality, web application capabilities, and performance upgrades, all at a fraction of
the cost of doing this independently. A key added feature obtained through this work will be database modules
that support curation and searches of gene expression data, and thus effort is proposed to curate gene
expression data to exploit this important capability. The look and feel of Echinobase will however be unique,
and be tailored to its user base. A further goal of this proposal is to develop an echinoderm embryological
anatomy schema using controlled vocabularies, and to improve identification of orthologous genes, not only
among echinoderms but also to common reference proteomes. These initiatives follow emerging best
practices, and hence ensure that Echinobase data can be readily shared with other resources. The assembly
and annotation of echinoderm genomes, including the identification of both genic and noncoding regulatory
features, will also be improved. Significant improvements to the curation of these genic and nongenic elements
are also proposed. The new resource will also support an interactive module to model GRNs. These
enhancements are directed at providing data types to support research for which the echinoderms have known
strengths and where they can contribute uniquely to reveal the mechanistic links between the genome and
development. The goal is to integrate these components to allow a user to readily navigate through these
different data types in the different species. Changes will also be made throughout, to make this resource
more useable, e.g. by controlling vocabularies, improving website design, and by providing training and
workshops, in order to increase the usefulness of the resource. The improvements suggested throughout this
proposal have wide community support as evidenced by results of our survey and community White Paper,
boh referenced in the component, and 34 attached letters of support.
1

Public health relevance
Overall, Project Narrative Echinobase is database for all genomic data types of the phylum Echinodermata, accessible via web browser, and enabling scientists to search, view, and download selected data to empower their own research. This facilitates research that explains how genomes control developmental process, which is needed to understand how genetic variations lead to birth, or other, defects.